An integrative structural biology approach to understanding metabolite recognition by cellular receptors

PROJECT SUMMARY
We propose to develop and apply innovative structural biology, NMR, and complementary biophysical
techniques to investigate molecular mechanisms of small molecule recognition by intracellular receptors. The
MHC-I-related protein 1 (MR1) binds, traffics, and displays endogenous metabolites derived from aberrant
metabolism to provide biomarkers of different intracellular states on the cell surface. It has been recently
established that several human viruses, including CMV, HSV and SARS-CoV-2, can directly interfere with known
components of the MR1 processing and ligand loading machinery. Thus, unravelling MR1's function will not only
help us understand fundamental principles of host/pathogen interactions, but also holds great promise for the
future development of universal therapies, since MR1 is highly conserved in the human population.
Despite a body of functional and structural studies, key barriers remain pertaining to (i) the molecular
determinants of specificity, given that MR1 can display a wide repertoire of chemically distinct ligands; (ii) how
binding of small molecules on a limited pocket of the MR1 groove induces global structural adaptations on MR1
surfaces, leading to the formation of unique features that can be leveraged for interactions with chaperones and
other components of the MR1 processing pathway, and (iii) How molecular chaperones, such as TAPBPR, can
catalyze exchange between free and bound ligands. Because of the dynamic nature of ligand and chaperone
interactions with MR1, and small size of the system by the standards of cryoEM, there are significant challenges
to conventional structural approaches. To address these bottlenecks, I have developed an integrative structural
approach, combining nuclear magnetic resonance (NMR) spectroscopy, complementary biophysical techniques
and computational modeling to characterize MR1/metabolite complexes and their interactions with chaperones.
Our preliminary data show that metabolite binding to MR1 creates unique conformational states, that can be
leveraged by chaperones to promote exchange.
In this renewal proposal, will further extend our integrative approach to elucidate molecular determinants of small
molecule/MR1 assembly and stability, including the contribution of protein dynamics to the selection of ligands
with distinct chemical features. Using a combination of methyl-based NMR constraints with structural modeling
and in vitro assays, we will delve deeper into MR1/chaperone interactions, and elucidate the mechanism of
ligand exchange. Our studies will provide a mechanistic paradigm of a highly malleable protein binding site that
can accommodate a wide range of chemically distinct ligands, and further our understanding of how presentation
of small molecules by MR1 can provide robust biomarkers for signaling different metabolic states.

Public health relevance
PROJECT NARRATIVE This proposal aims to elucidate fundamental protein/small molecule interaction mechanisms that are relevant for cellular communication of different metabolic states. We propose to apply complementary structural biology, NMR and biophysical techniques, to elucidate the selection of metabolite ligands for binding to the MR1 protein, including the role of molecular chaperones that are often targeted by several important human viruses. Our research will expand our understanding of how a unique protein receptor can sense the presence of specific metabolites, to signal different cellular states.